Revealing the role of blood microbiome in childhood asthma

Project Summary/Abstract
Asthma is one of the most common chronic respiratory diseases worldwide. Microbial dysbiosis in the gut
and lungs has increasingly been associated with the incidence and severity of asthma, indicating the potential
of the microbiome to be a determinant factor in asthma pathogenesis. However, as the most likely connection
between the gut and lungs, the role of the blood microbiome in the “gut–lung axis” is still unclear for asthma
pathogenesis due to the lack of cost-effective and high-throughput sequencing methods. Indeed, it is either
impossible, or prohibitively expensive, for conventional sequencing methods to handle microbial DNA
samples that are in trace amounts, heavily degraded, or dominated by host DNA, e.g., in human blood. We
hypothesize that the presence of microorganisms in the blood is related to the risk of asthma occurrence,
and these microbial blood biomarkers can be captured by a reduced metagenomic sequencing method for
diagnosis or even early detection of asthma with the help of a deep learning framework. In this application, a
strain-resolved computational pipeline for the reduced metagenomic sequencing will be developed to profile
the blood microbiome in the “Vitamin D Antenatal Asthma Reduction Trial” --- an ongoing randomized, double-
blind, placebo-controlled clinical trial of 881 pregnant women with both questionnaires and maternal, cord,
and child blood samples available. Meanwhile, a deep-learning framework will be developed to optimize the
accuracy of diagnosis and prediction models for asthma using blood microbiome data. Finally, with the aid of
the new computational pipeline and deep-learning framework, the role of the blood microbiome in the gut–
lung axis and asthma pathogenesis will be investigated. Dr. Sun’s trainings in molecular biology,
bioinformatics and metagenomics have prepared him well for this proposed research. However,
understanding the molecular basis connecting asthma through the analysis of blood microbiome data is a
challenging task that requires further training in specific areas. Dr. Sun will leverage the excellent intellectual
environment of Harvard Medical School (HMS) and its teaching hospital Brigham and Women’s Hospital
(BWH). He will have access to extensive computational resources at BWH and HMS. Through formal
coursework and workshops, and with the help of a strong mentoring team and a world-class advisory
committee with complementary expertise, Dr. Sun will immerse himself in a training program focusing on
advanced programming, statistical modeling, deep learning, respiratory pathophysiology, and clinical
translation. Dr. Sun will meet with his two mentors and advisory committee members on a regular or needed
basis to present his progress and get prompt feedback and advice. Altogether, Dr. Sun’s training and research
plan will enable him to expand his current skill set to include the ability to address the challenges of low
microbial biomass sequencing in blood sample, deep learning in microbiome study and identifying the role of
blood microbes in asthma pathogenesis, and ultimately contribute to the precision medicine of lung diseases.

Public health relevance
Project Narrative A key goal of this project is to reveal the role of the blood microbiome in asthma pathogenesis. The proposed research is relevant to public health because it enables us to systematically identify candidate causal microbial strains that can potentially prevent asthma. Thus, the proposed research is relevant to NIH’s mission towards developing fundamental knowledge about the nature and behavior of living systems and the application of that knowledge to enhance human health and reduce illness.